PROSTAGLANDINS &SKELETAL MUSCLE HYPERTROPHY IN VITRO

Passive tension (i.e. stretch) is a primary growth regulator in skeletal and cardiac muscle. Stretch stimulates muscle growth while decreased tension leads to muscle atrophy. The mechanism which couples stretch to growth or atrophy is unknown. The objective of this project is to study the molecular mechanisms by which passive tension regulates muscle protein synthesis rates. We will utilize new computerized Mechanical Cell Stimulator devices to place tissue cultured cells under repetitive passive tensions. Mechanical stimulation of differentiated avian skeletal muscle cells increases messengers for mechanical stimulation of cell growth in this tissue culture model system. PGs are also second messengers for a number of defined growth factors where they alter cell growth by generating additional messengers such as altered calcium fluxes, cyclic nucleotides, and phosphoinositides. We intend to use the Mechanical Cell Stimulator systems to address two important questions: (1) how does mechanical stimulation of muscle cells increased their PG production; and (2) which second messengers couple stretch-induced PGs to muscle protein synthesis rates? To address question 1, the activity of two enzymes (phospholipase A2 and phospholipase C) responsible for providing the precursor of PGs (arachidonic acid) will be assayed biochemically following various patterns of mechanical stimulation. In the second part of this project we will analyze the relationship of stretch-induced PGs to altered calcium fluxes, cyclic nucleotide levels, and phosphoinositides using radioactive tracers, radioimmunoassays, and immunohistochemical techniques. The relationship of these second messengers to total muscle protein synthesis rates and the synthesis of specific proteins will be studied. The results from these studies may lead to a better understanding of the molecular signaling processes regulating muscle cell growth by stretch. This knowledge might lead to the development of new pharmacological agents to limit skeletal muscle wasting in patients with limited mobility such as paraplegics and the elderly. It could also lead to nw treatments for stretch- induced cardiac hypertrophy.